PROPHYLACTIC MANEUVERS TO PREVENT SHOULDER DYSTOCIA

To determine if initiation of prophylactic obstetrical maneuvers, including suprapubic pressure and McRoberts (hip flexion), aids in the prevention of shoulder dystocia in potentially large for gestational age infants